Optimizing the ethical research engagement for pregnant women living with HIV and their children

PROJECT SUMMARY
Research involving pregnant women living with HIV (PWLHIV) and their children has increased in recent years
to better understand the health outcomes related to new antiretroviral regimens within the antenatal period and
outcomes related to being born to a mother living with HIV. While some insights have been reached regarding
the issues faced by these populations when engaging in research, very little is known about what potential
harms arise from their participation and their preferred method for communication of study results. Therefore,
there is a critical need for an empiric, person-centered approach to understand the ethical issues that can arise
from research involving PWLHIV and their young children due to the intersectionality of multiple vulnerabilities
within these populations. By providing more empirical evidence to inform ethical research activities, research
programs will gain critical guidance on how to engage this population in future studies. The proposed activities
will occur within the context of our ongoing Tabiri Study (R01HD104552), which is currently enrolling 1000
Kenyan women (half of whom live with HIV) who are pregnant or immediately post-partum and following them
and their children for 24 months. The specific objectives of this application are to: (1) provide an evidentiary
basis to guide the ethical and equitable conduct of biomedical research involving PWLHIV and their young chil-
dren, and (2) create and disseminate a stakeholder-informed bioethics toolkit to support investigators engaging
in research with similar populations. Within the first aim, we will evaluate perspectives on research participation
from key stakeholders, including PWLHIV who are actively enrolled in ongoing maternal-child health outcomes
research in Kenya. To do this, we will recruit key stakeholders, including PWLHIV and their partners, village
elders, healthcare workers, research assistants, community health workers, and research ethics committee
members, for in-depth, qualitative interviews to understand a myriad of topics related to research participation.
Within the second aim, we will create and disseminate a bioethical toolkit for engaging PWLHIV and their chil-
dren in research. The results from the key stakeholder interviews from the first part of our study will inform the
creation of ethical guidelines for research engaging PWLHIV and their young children. We will then utilize a
series of participatory design workshops, including PWLHIV, university ethics committee members, and key
stakeholders, guided by an international ethics framework, to develop a bioethical toolkit. The toolkit will outline
key aspects of research, from study design to dissemination of results. We will then disseminate the toolkit us-
ing three strategies: (1) a local symposium, inviting ethics committee members from across Kenya; (2) the re-
search networks of the International epidemiological Databases to Evaluate AIDS Regional Consortium and
the Academic Model Providing Access to Healthcare (AMPATH) consortium; and (3) an exhibition booth at an
international HIV conference. Through these aims, we will gain critical insights to develop the evidence-based
resources needed to optimize stakeholder-engaged, ethical research focused on PWLHIV and their children.

Public health relevance
PROJECT NARRATIVE To improve health outcomes for pregnant women living with HIV and their young children, they need to be a part of the research defining their care in a manner which is ethical and meaningful for this population. The proposed research is relevant to public health because it will create a bioethical toolkit to provide recommendations for research involving pregnant women living with HIV and their young children. Thus, the proposed research is relevant to the NIH’s mission, as it lays the foundation for research that enhances health and reduces the burdens of human disability.